Pathology Peer Review and Pathology Support for the DNTP and DIR at NIEHS (Integrated Laboratory Systems an Inotiv Company)

The subject contract supports the Division of Translational Toxicology (DTT) in identifying hazards to prevent diseases or adverse effects caused by environmental exposure to chemical or physical agents. The pathology support services provided under this contract are essential for evaluating pathology data from DTT studies, ensuring the consistency and accuracy of that data.
Most of these studies are toxicity and carcinogenicity bioassays that investigate the cancer-causing potential or other potentially toxic effects of chemicals or agents. Other studies include immunotoxicity and reproductive and developmental toxicity studies. These studies evaluate the effects of various chemicals or physical agents of public health concern. The pathology data generated are used by the DTT to prepare final toxicity and toxicology/carcinogenicity technical reports, which government regulatory agencies consult when making regulatory decisions about chemical or agent use and exposure. Hence there is a direct benefit to the government and to the public. It is therefore crucial that the data be complete and accurate, emphasizing the importance of the pathology peer review services provided by this contract.
Additionally, the Pathology Support Contract services are used to generate pathology data for NIEHS scientists at different stages of laboratory-based research studies. This data often contributes to manuscripts and reports for publication in peer-reviewed scientific journals.
In summary, the primary aim of this contract is to continue delivering quality, professional pathology, histology, necropsy, and molecular biology/pathology services to the NTP/DTT and NIEHS scientists in the interest of public health and in keeping with the mission of the NIH/HHS.

Public health relevance
This contract supports the Division of Translational Toxicology (DTT) in identifying hazards, specifically by evaluating the harmful effects of various chemicals or physical agents. The goal is to prevent diseases or adverse effects caused by environmental exposure to these substances, which are of public health concern.